Optimizing colorectal cancer prevention: a multi-disciplinary, population-based investigation of serrated polyps using risk prediction and modeling

Project Summary/Abstract
Colorectal cancer (CRC), the second most common cause of cancer deaths in the US, can be prevented
through colonoscopy, during which potentially pre-cancerous polyps are removed from the colon. Serrated
polyps may precede up to 30% of CRC, but unlike adenomatous polyps (their more common counterparts),
there is limited data about their outcomes and natural history. Current clinical guidelines highlight that there is
a critical lack of evidence available on future risks in patients with serrated polyps. To address this
knowledge gap, this project proposes to combine the comprehensive data on colonoscopy patients,
procedures, and pathology of the New Hampshire Colonoscopy Registry (NHCR), which has been collecting
data from endoscopy sites across NH since 2004, with the statistical and risk prediction modeling expertise of
the Geisel School of Medicine at Dartmouth College and the internationally recognized micro-simulation
modelers of the Cancer Intervention and Surveillance Network (CISNET). The development and application of
microsimulation models to characterize how digestive diseases progress is a key need for improving public
health.
In Aim 1.1, NHCR data, including key information on polyp subtype, size and location in the colon as well as
the interval between index and subsequent colonoscopy, will be used to develop a risk-prediction model that
can generate accurate personalized estimates of future risk in patients with serrated polyps. In Aim 1.2,
NHCR data on patient risk factors and characteristics will be added to this model, to further refine the
personalized estimates of future risk. In Aim 2.1, these risk estimates and additional NHCR data from patients
with serrated lesions will be used by members of the CISNET Colorectal Group to inform and expand
existing colorectal cancer micro-simulation models (SimCRC and MISCAN), and, in Aim 2.2, adding data
from the literature, to validate these models. Aim 3.1 will use these expanded micro-simulation models to
assess the clinical and cost effectiveness of recommended follow-up intervals for colonoscopy
surveillance in patients with serrated polyps, stratified by specific polyp characteristics. Aim 3.2 will use
the models to assess the effectiveness of recommended follow-up intervals for surveillance in patients with
serrated polyps stratified by both polyp and patient characteristics.
By linking the data of the NHCR with the biostatistical tools of risk-prediction and micro-simulation modelling,
this study will significantly advance the scientific evidence-base and transform the landscape of serrated polyp
management, helping colonoscopy achieve its tremendous potential for reducing CRC incidence and mortality.

Public health relevance
Project Narrative Despite being preventable, colorectal cancer is the second most common cause of death from cancer in the US. Almost all colorectal cancer arises from small growths in the colon known as polyps, which are found and painlessly removed during colonoscopy to prevent their possible progression to cancer. In this study, we will clarify the best management for patients with serrated polyps, a type of polyp that leads to as much as 30% of colorectal cancer, providing evidence that will improve colorectal cancer prevention.